Adhesion GPCR regulation of acute myeloid leukemia stem cells - Resubmission - 1

Despite advances in our understanding of the genetic origins of AML, treatment options have remained
essentially unchanged for 30 years, and clinical outcomes remain poor. Leukemia stem cells (LSCs) represent
the population of blasts that are resistant to chemotherapy and re-initiate AML after therapy; thus, this subset of
blasts must be eradicated to cure disease. Unfortunately, therapies developed specifically to target LSCs have
yet to be validated in the clinic. We and others recently identified a novel AML antigen, CD97, that is expressed
in the vast majority of human AMLs. Our recently published studies have revealed several features of CD97 that
suggest that it may be an excellent therapeutic target in AML: 1) CD97 is one of the most commonly expressed
AML antigens; 2) CD97 regulates blast growth, survival, and differentiation; 3) CD97 regulates LSC function, as
demonstrated in serial transplantation experiments of primary AML; and, 4) CD97 is not required for HSC
function, suggesting low toxicity of CD97-targeting therapeutics. Highlighting its clinical importance, CD97 mRNA
expression is an independent predictor of disease-free and overall survival in AML.
CD97 is an adhesion class G-protein coupled receptor (aGPCR) characterized by a long, extracellular ligand-
binding domain and a GPCR-Autoproteolysis-INducing (GAIN) domain that can induce signals that may or may
not require extracellular domain shedding. Isoforms of CD97 produced by alternative splicing differ in the
composition of the ligand-binding domain, but at present, it is unclear if the various CD97 isoforms mediate
unique or overlapping roles in AML. Our overall hypothesis is that the various CD97 isoforms play distinct roles
in leukemogenesis and LSC self-renewal by virtue of their unique ligand binding and/or signaling properties. Our
specific goals are to determine the role of CD97 isoforms in leukemic transformation and LSC function, to
identify the molecular and structural requirements for CD97 activity, and to utilize novel human synthetic
antibodies (sAbs) against CD97 with different epitope specificities to evaluate the function of CD97 as well as
test their anti-leukemic activity. We will determine the roles of the various structural subdomains of CD97 required
for LSC function utilizing our novel CD97 Abs, CD97 constructs expressing multiple naturally occurring and
engineered structural variants of CD97, and complementary in vitro and in vivo models of mouse and human
AML.
Given our team's complementary expertise in LSC biology, antibody engineering, and aGPCR biology, we
are uniquely positioned to investigate the mechanisms of CD97 signaling and function in LSCs. Collectively,
these studies will dramatically increase our understanding of the molecular mechanisms that regulate LSC self-
renewal and help expedite translation of CD97 antibody therapies to the clinic. Finally, these studies may have
broader consequences since CD97 plays disease-modifying roles in other human cancers.

Public health relevance
NARRATIVE CD97 is an adhesion class G-protein coupled receptor (aGPCR) frequently expressed in human acute myeloid leukemia (AML) that is required for LSC self-renewal. CD97 exists as three isoforms with potential differences in ligand binding and signaling profiles; however, it is not clear if there are isoform-specific roles for CD97 in LSCs. We will use a combination of genetic and molecular approaches, including novel human synthetic CD97 antibodies we have generated, to identify the physiologically relevant interaction domains as well as the structural and signaling requirements for CD97 function; these studies will not only yield novel insights into the mechanisms that regulate LSC self-renewal, but identify specific antibody reagents that may be quickly translated to the clinic.